Contribution of Biological, Physiological and Gait Mechanisms to High Metabolic Cost of Walking in Older Adults

PROJECT SUMMARY
Age-related decline in mobility is strongly associated with loss of independence and increased risk of frailty and
mortality in older adults. Mobility decline is typically preceded by a slowing of gait speed, which is closely reflected
by a decrease in peak energetic capacity (VO2 peak) and an increase in the energetic cost of walking. Although
age-related declines in peak capacity and fitness are well-established, mechanisms contributing to a higher
energetic cost of walking are under-studied. In response to RFA–AG-25-030, this application proposes to
investigate bioenergetic and physiological mechanisms underlying slow gait speed and high energetic cost of
walking. We will use clinical, laboratory, and sensor-based free-living assessments to detect changes in health
and mobility consistent with the onset and progression of energetic inefficiencies in a population of 100 diverse
older participants aged ≥70 years from the Johns Hopkins Older Americans Independence Center (OAIC)
registry who vary in demographics, health, and function. We will conduct baseline and two-year assessments of
muscle quantity and metabolic quality, gait mechanics, free-living physical activity and sedentary behaviors, and
biological (blood biomarkers) and physiological (heart rate and variability, glucose control) indicators of health in
older adults to compare their relative importance to preserving gait speed and energetic efficiency. Our
overarching hypothesis is that deficits in energy production and utilization induced by aging-related changes
across multiple aspects of energy metabolism, gait mechanics, physical activity, and clinical/subclinical disease
burden contribute to slowed gait and poor mobility and to their progression with advancing age. Specifically, as
older adults move along the gait speed continuum, heterogeneity in muscle quality and metabolism, gait
mechanics and characteristics, physical activity and sedentary behavior, and disease burden contribute to
energetic (in)efficiency and trajectory of gait speed decline. Individuals who maintain high energetic efficiency
are more likely to maintain gait speed, with minimal decline over time. Our specific aims are to: (1) determine
the cross-sectional and longitudinal associations of muscle quantity and metabolic quality, and gait mechanics,
with gait speed and the energetic cost of walking; (2) establish the cross-sectional and longitudinal associations
of novel sensor-based measures of free-living physical activity and sedentary behaviors, heart rate and
variability, and glucose control with gait speed and the energetic cost of walking; and (3) quantify the relative
predictive performance -and interactions between- the laboratory and free-living measures from Aims 1 and 2,
as well as traditional blood biomarkers, as contributors to high energetic cost of walking and slow gait speed
using machine learning methods. Conducting these rigorous assessments in an older at-risk population where
interventions may still be impactful is especially timely, given the population-wide proliferation of metabolic-
associated diseases in older adults.

Public health relevance
PROJECT NARRATIVE Mobility decline in late life is typically preceded by a slowing of gait speed and an increase in the energetic cost of walking. This application proposes to investigate bioenergetic and physiological mechanisms underlying slow gait speed and high energetic cost of walking in older adults using clinical, laboratory, and sensor-based assessments to detect changes in health and mobility consistent with the onset and progression of energetic inefficiencies. We will conduct rigorous assessments and rank their relative importance to assist in developing targets for future intervention efforts.